Applying induced pluripotent stem cell derived endothelial cells to regenerative therapy in chronic limb threatening ischemia

Peripheral arterial disease (PAD) is highly prevalent among the Veteran population. Veterans
experience PAD onset at an earlier age than their non-Veteran counterparts and are at increased risk
of experiencing adverse outcomes from peripheral arterial disease. Chronic limb threatening ischemia
(CLTI), the most severe form of peripheral arterial disease, is a significant cause of morbidity, including
persistent pain at rest, neuronal dysfunction, and ultimately limb loss. While endovascular and surgical
treatment options have advanced, many patients are not candidates for revascularization due to
anatomic constraints or co-morbidities. Therapies for these “no-option CLTI” patients are limited to
palliation consisting of pain control and major amputation, both of which lead to significant morbidity
and disability. Improved therapeutic modalities to treat this “no-option CLTI” population and to
prevent limb loss are desperately needed.
Stem cell-based therapies have emerged as a promising new modality to treat this “no-option CLTI”
population. The advent of induced pluripotent stem cell (iPSC) technology allows for an infinitely
reproducible and scalable source of stem cells. This technology was rendered applicable to vascular
disease by the establishment of reliable directed differentiation of said stem cells to the myriad vascular
cell types required for a functional blood vessel. Our prior work overcame the barrier of premature loss
of EC function and replicative senescence in culture, opening the door to the next steps in developing
iPSC-EC therapeutics.
This proposal aims to (1) validate the survival and function of clinical grade iPSC-ECs in implantable
and resorbable platelet lysate hydrogels, and (2) quantify the restoration of limb perfusion and function
after implantation of hydrogels containing iPSC-ECs into ischemic mouse hindlimbs. This work will
generate a critical pre-clinical animal model of utilizing PAD patient-derived iPSC-ECs to promote local
vascular regeneration in ischemic limbs as a novel therapy for CLTI.

Public health relevance
Veterans bear a disproportionate burden of disability as a result of chronic limb threatening ischemia (CLTI) compared to their age-matched non-Veteran counterparts, often culminating in limb loss. Restoring of blood flow through surgery is the ideal treatment, however, not all Veterans are able to successfully undergo surgery to achieve this. New therapies aimed at local vascular regeneration to restore perfusion and function of the ischemic leg are paramount. This study aims to generate and embed clinical grade stem cell-derived endothelial cells in a resorbable platelet lysate hydrogel, and to implant these cells into ischemic mouse hindlimbs to quantify the restoration of perfusion and function. This is a critical step toward applying induced pluripotent stem cells to vascular regeneration to improve therapies for Veterans with CLTI.